Data Science Core

Bioinformatics Core
Project Summary
The Bioinformatics Core has served as a key player in the overall success of the NE-INBRE project by facilitating
access to resources, technology, services, and providing training to the network members in the use of
computational and data analysis tools in bioinformatics. Over the past five years, the use of high-throughput
technologies including next-generation sequencing (NGS) has become a commonplace by the NE-INBRE
investigators. Consequently, there has been a tremendous need for developing computational and bioinformatic
infrastructure for the collection, processing, storage, and analysis of large-scale datasets. With parallel
developments in the ever-changing experimental technologies, new bioinformatic algorithms and tools need to be
developed or adopted to meet the growing data analysis needs of the research community. Given the nature of
this complexity, it is extremely challenging for individual institutions to locally develop and maintain sophisticated
infrastructure and technical expertise in bioinformatics. The primary goal of this Bioinformatics Core is to develop
such environment, technology, tools, and services and make them accessible to all members in the NE-INBRE
network. The main objectives of the Core include the development of cutting-edge infrastructure for future needs
while continuing to support and train NE-INBRE Scholars and investigators in the use of resources and
technologies. The Bioinformatics Core will be equipped to provide the needed infrastructure, access to resources,
technical support, education and mentoring opportunities for the NE-INBRE network members.